Immune signatures of vaccine responses in vulnerable populations

ABSTRACT OF PARENT AWARD: We
molecular
with
These
responsiveness.
longstanding
understudied
responsiveness.
different
deeply
mathematical
determine
effectiveness.
shared
characterizes
development
therapeutic
propose a deep interrogation and a systems approach that will identify
signatures to vaccination across three cohorts of vulnerable patient populations: autoimmune patients
B cell depletion, aged and frail individuals, and patients with sickle cell disease who are f unctionally asplenic.
distinct populations share a dysregulated inflammatory milieu that is linked to poor vaccination
We have assembled an interdisciplinary team of investigators with a track record of
and productive ollaborations. We use a systems approach t hat combines well-defined and
cohorts with unbiased large-scale profiling to elucidate signatures defining vaccine
This goal wil l be accomplished by 1) examining three vulnerable patient cohorts challenged with
vaccines, i ncluding novel mRNA vaccines nd ne shared vaccine; 2) using shared platforms that
interrogate immune responses f rom blood and limited-access compartments, and 3) refining new
tools for multidimensional analysis of data to identify active pathways and modules and to
specific connections among components in the immune network that contribute to differential vaccine
This effort capitalizes on recent advances in single-cell and spatial immune profiling methods and
immunologic and proteomic platforms to create a novel public resource for vulnerable populations that
diverse states of the human immune system. Integration across our cohorts will support the
of molecular signatures of vaccination responses and identify critical pathways relevant to potential
strategies.

Public health relevance
Contact PD/PI: MONTGOMERY, RUTH R Project narrative We propose a deep interrogation and a systems approach that will identify molecular signatures to vaccination across three cohorts of vulnerable patient populations that share a dysregulated inflammatory milieu: autoimmune patients treated with B cell depletion therapy, aged and frail individuals, and patients with sickle cell disease. Project Narrative Page 119